A Transcriptional Program Modulating Epithelial Death and Innate Function - Project 1

Acute Respiratory Depress Syndrome (ARDS) can be a devastating disorder and prior
studies have focused mainly on its hyper-inflammatory state. However, mounting data
suggest that immune suppression partakes in this disorder, the molecular mechanisms of
which remain unclear. This Project investigates a unique molecular model whereby a lysine
acetyltransferase termed general control of amino acid synthesis protein 5-like 2 (Gcn5l2),
normally targeted for its disposal in cells by a ubiquitin E3 ligase subunit, Fbxo24, executes
alveolar epithelial cell death and suppression of genes involved in innate immunity through
histone modification. Our hypothesis is that Gcn5l2, normally kept in check by ubiquitin-
mediated degradation, is an endotoxin-responsive executioner of innate immune suppression
and epithelial cellular death in experimental ARDS. As a corollary to this hypothesis, we
propose that Gcn5l2 chemical inhibition will attenuate acetyltransferase activity. Hence, in
this application we will first elucidate how endotoxin increases Gcn5l2 levels by abrogating its
Fbxo24 E3 ubiquitin ligase mediated proteolysis in experimental lung injury (Aim 1). We will
specifically investigate how Fbxo24 targets Gcn5l2 for its degradation using complementary
in vitro and in vivo genetic models and then evaluate how endotoxin abrogates molecular
interaction of these partners. Next, we will optimize the pharmacologic design and test a
novel small molecule that exhibits distinct, and yet complementary immune modulatory and
cytoprotective properties in 2-hit models of immune suppression and in an ex vivo isolated
human lung system (Aim 2). These studies will provide a new pathobiologic model of immune
dysregulation that will serve as a platform for generating small molecule modulators that
optimize epithelial cell survival and restore host defense in subjects with severe critical
illness.

Public health relevance
Acute respiratory distress syndrome (ARDS) from severe pneumonia is a devastating illness with high mortality. Most studies have investigated lung inflammation in ARDS, although many people are prone to immune suppression with impaired ability to fight infections. We have discovered a new model that may explain immune suppression in ARDS that led us to propose developing a compound that restores immune function. This discovery fulfills an unmet need in this critical illness.